The role of TCF1 in CD8+ tissue resident memory T cell formation and maintenance across distinct tissues

SUMMARY
Formation of long-lived memory T cells is a critical feature of the adaptive immune system which enables the
efficient control of recurrent infection. Tissue-resident memory T (TRM) cells are a unique and transcriptionally
heterogenous population of memory T cells that provide host protection against pathogens through their
positioning within barrier tissues and rapid effector response. Current treatments for viral infections lack the
ability to enhance the TRM cell protective response largely because our understanding of TRM biology lags that of
circulating memory T cell populations. To dissect the transcriptional regulators of TRM across distinct tissues, I
have chosen to focus on T cell factor 1 (TCF1), a transcription factor that is critical for the formation of central
memory T cells yet is largely unstudied in the context of TRM cell biology. TCF1 has been shown to repress lung
TRM, however its role in TRM cell formation and maintenance in other non-lymphoid tissues such as the intestines,
salivary gland, kidney, liver, and pancreas are unknown. Furthermore, TCF1 is expressed in multiple isoforms
yet the role of the individual isoforms of TCF1 have never been investigated in the context of TRM cell formation
in any tissue. Additionally, there is a growing body of evidence which suggests that TCF1 expression during the
first week of an acute viral infection defines cells that are fated to become memory cells versus terminal effector
cells. However, the mechanism behind TCF1 regulation of this fate decision remains largely unknown. This
proposal seeks to address these gaps in knowledge by investigating the hypothesis that TCF1 has distinct roles
in regulating CD8+ T cells throughout the course of infection from effector CD8+ cell expansion, memory precursor
formation, and TRM cell formation and maintenance. To investigate this hypothesis, we will complete the following
two specific aims: (Aim 1) Determine the role of TCF1 in the formation and maintenance of CD8+ TRM cells across
distinct tissues; (Aim 2) Investigate the role of TCF1 in early effector CD8+ expansion and memory precursor cell
formation across distinct tissues. Identification of the molecular mechanisms regulating TRM cell formation and
maintenance will build on our understanding of the transcriptional regulation of TRM and will have a positive impact
on therapeutics designed to modulate tissue-specific TRM. The experiments and career development
opportunities outlines in this proposal will greatly prepare the applicant for a successful career in academic
research.

Public health relevance
PROJECT NARRATIVE CD8+ tissue-resident memory T (TRM) cells are a subset of T cells that function as first responders to infections reencountered at barrier sites of the body, but TRM cells can also be causative agents in some inflammatory diseases. The proposed study aims to define if and how the transcription factor T cell factor 7 regulates TRM cell formation and maintenance within distinct tissues. This research has the potential to elucidate the regional differences in TRM cells so that we may be able to develop vaccines that can target specific tissues for disease prevention.